Action and interaction of ionotropic and metabotropic neurotransmission

Project Abstract
The many classes of neurons in the mammalian brain use many different neurotransmitters to communicate.
Nevertheless, it has generally been assumed that each neuron uses one principal neurotransmitter. This
notion has dominated the analysis of the contributions of synaptic transmission to circuit function and behavior.
However, we and others have found that many neurons in the mammalian brain actually release several
neurotransmitters at the same time, often targeting each neurotransmitter to a specific and different
postsynaptic cell class. We propose that the co-released neurotransmitters act in concert to have consistent
and mutually reinforcing effects on their enclosing circuit. Here we propose to study the integration and
coordination of peptidergic, GABAergic, and cholinergic signaling and reveal how these diverse signaling
molecules act together to dictate the activity and plasticity state of cerebral cortex. The pathways that we have
uncovered are potentially powerful means of regulating cortical function and may, in the future, be exploited to
restore cognitive function in neurodegenerative disorders.

Public health relevance
Project Narrative Neurons in the brain communicate using a large diversity of chemical signals and it is the concerted action of these signals that determine the activity and plasticity of neural circuits as well as animal behavior. We propose to follow up on previous findings from the lab that reveal that many individual neurons actually release multiple chemicals, each onto different classes of cells. We will determine how the integrated and simultaneous action of these molecules controls brain circuitry.